CLINICAL MEASUREMENT OF MICROVASCULAR BLOOD IN SICKLE CELL PATIENTS

Current viewpoints assume that manifestations of sickle cell disease result from the obstruction of capillary networks by abnormal erythrocytes during deoxygenation. Using a commercially available Laser Doppler Velocimeter (Med Pacific LD 5000) we propose to monitor non-invasively cutaneous blood flow in stable sickle cell patients under various conditions of steady state and perturbed flow. Additionally, since red cell deformability is a key factor in determining capillary flow we will monitor in vitro filtration rates of cells under various conditions.